Colorado Department of Public Health and Environment application for the Flexible Funding Model-Maintenance for State Manufactured Food Regulatory Program

Project Summary/Abstract
For
Colorado Department of Public Health & Environment Flexible Funding Model –
Maintenance for State Manufactured Food Regulatory Programs
It is the intent of the Colorado Department of Public Health and Environment, Division
of Environmental Health and Sustainability (CDPHE-DEHS) to use this opportunity to
manage and maintain conformance with the Manufactured Food Regulatory Program
Standards (MFRPS) by implementing the policies, procedures and protocols used by our
Manufactured Foods Program staff when inspecting and regulating the manufactured
foods industry in Colorado. Our goal is to ensure that staff working within the program
is well trained, knowledgeable and will consistently and uniformly apply that
knowledge to the situations encountered while inspecting and providing technical
guidance, education and outreach to the regulated community. In 2020, CDPHE was
determined to be in full conformance and full implementation with the 2019 MFRPS
standards for its manufactured food regulatory inspection program. The requirement
for states to be in full conformance with the MFRPS as a condition of continued FDA
contractual work and the need to apply these same standards to the State program
requires the dedication of significant resources that are not currently available to
Colorado’s program. Maintaining a solid program foundation will continue to help
improve the program now and for the future.
The goal is to have the work conducted by Colorado’s program to continue to be
recognized for its quality and consistency related to inspections, laboratory analytical
findings, industry outreach and staff training based on the requirements of the 2022
MFRPS. This will allow the agency to meet its goal of ensuring manufactured foods in
Colorado and all manufactured food products that leave the state are safe. The
agency is committed to help achieve FDA’s goal of an integrated food safety system
and ensure that Colorado’s inspections, investigations, laboratory findings and
program products are recognized as equivalent to the work product of other states or
the FDA that are using the MFRPS as the foundation for their programs.

Public health relevance
Project Narrative For Colorado Department of Public Health & Environment Flexible Funding Model – Maintenance for State Manufactured Food Regulatory Programs Colorado’s proposed project and work to remain in full conformance and fully implementing the 2022 MFRPS will ensure that trained, qualified staff will hold food manufacturers in the state to national food safety standards and food products are safe for consumption. Through conformance with the MFRPS, Colorado will develop and maintain best practices for a high-quality manufactured food regulatory program and enhance food safety by continuing a uniform basis for measuring and improving the performance of the program. These activities will provide FDA the foundation for pursuing regulatory action when deemed necessary and improve domestic mutual reliance.